Illuminating the distribution of extreme evolutionary constraint in the human genome from fetal demise to severe developmental disorders

Abstract
Natural selection purges deleterious mutations from populations in genomic regions impacting survival or
reproductive capacity. Recent genetic studies of massive population cohorts have revealed a continuous
distribution across the human genome of this constraint on deleterious mutations. Large-scale association
studies have found mutations in strongly constrained genomic regions to be major risk factors in many childhood
developmental disorders (DDs), suggesting that highly constrained sequences are likely to play key roles in
development. However, genetic studies of fetal demise after the first trimester (FD), an extreme outcome of DDs,
have thus far been limited in scope and size. The establishment by my mentors of an international Fetal
Genomics Consortium to sequence 10,500 samples (3,500 FD cases and their family members) ascertained for
FD of suspected genetic etiology now offers an unprecedented opportunity to illuminate the most extreme
consequences of mutation across individual genes and dosage sensitive genomic segments critical for human
development. In this fellowship, I will integrate whole-genome sequencing and autopsy data from this cohort
together with data from previously established DD cohorts to discover and functionally characterize mutationally
intolerant loci in the human genome. I will first define patterns of genetic variation in FD across constraint metrics
(loss-of-function, missense, and noncoding) and genomic variation classes (point mutations, indels, structural
variants, and repeat expansions), and investigate biases in these patterns with respect to fetal sex and mutational
parent-of-origin. I will then adapt a statistical framework for disease association capable of integrating evidence
from all coding and noncoding variant classes with prioritization of constrained regions, which I will apply to
perform novel gene discovery in FD (Aim 1). I will leverage these findings to generate functional predictions of
mutationally intolerant loci by defining the biological networks of activity and the cell types in which they are likely
to operate early in development (Aim 2). Finally, I will test these functional hypotheses across DDs that do not
result in FD, including liveborn fetal structural abnormalities, neurodevelopmental disorders, and congenital
anomalies (Aim 3). In parallel with these research aims, an exceptional team of six mentors and advisors across
multiple disciplines, career stages, and institutions will provide didactic training, hands-on research support,
regular opportunities for presentation in seminars and conferences, and a variety of soft skill development
sessions that directly align with my career objectives during my PhD training. Collectively, the aims outlined in
this proposal will take advantage of unique tools and resources to yield novel insights into the etiology of the
extremes along the continuum of developmental anomalies and evolutionary constraint, and will serve as an
outstanding training opportunity for me in computational, statistical, and functional disease genomics.

Public health relevance
Project Narrative Mutations in the most evolutionarily conserved regions of the human genome have been shown to be strong risk factors for many developmental anomalies in humans. In this proposal, I will leverage whole-genome sequencing data from an unprecedented trio cohort ascertained for intrauterine fetal death, one of the most extreme developmental disorders, to discover mutationally intolerant loci in the human genome, define functional features that are predictive of these loci, and evaluate these predictors against a continuum of severe developmental disorders. This work will establish a statistical framework for disease association capable of integrating evidence from all variation classes weighted by metrics of evolutionary constraint, and will yield new insights into the roles that mutationally intolerant loci play in the etiologies of fetal loss and other severe developmental anomalies.